CORE--DISHWASHING

The centralized dish-washing service hs existed since 1986 when the Arizona Cancer Center completed it own building. The service provide dish- washing and autoclaving services to those Cancer Center members that are located in the Cancer Center building. This is an essential core service for bench scientists. The operation of this centralized service means that individual investigators do not have to maintain space, equipment and personnel to perform these essential tasks. Personnel funds are requested to pay two full-time employees in the centralized service. Supplies for the service will be paid by the investigators through a charge back system.